CMV Control of Host Membrane Trafficking

PROJECT SUMMARY / ABSTRACT
Viruses commandeer host membrane trafficking to promote viral replication. While this is a critical control point
for virus infection, how viruses hijack host proteins and pathways to promote infection is incompletely
understood. Viral-mediated alterations in membrane trafficking are best understood for building replication
compartments and sites of assembly for RNA viruses. However, much less is known about how DNA viruses
influence membrane remodeling in the host. Human cytomegalovirus (CMV) is a complex DNA virus and a
member of the herpesvirus family that establishes a lifelong infection in the host. During infection, CMV
induces alterations in membrane trafficking that results in increased biogenesis of multivesicular bodies
(MVBs), organelles important for signaling and exocytosis or degradation of cargo. During infection, MVBs
become loaded with virus particles and dense bodies (vesicles of viral tegument protein). The mechanisms by
which CMV controls host membrane trafficking pathways, and particularly MVB biogenesis, are not
understood. Therefore, defining the viral proteins and host targets important for the regulation of membrane
trafficking is an important goal with important implications for host and virus biology. We have identified two
CMV proteins, pUL135 and pUL136, which regulate MVB biogenesis. Recombinant viruses lacking UL135 or
UL136 genes exhibit profound alterations in MVB biogenesis and the incorporation of viral cargo into MVB.
Consistent with these phenotypes, we have identified host interacting proteins for both pUL135 and pUL136
proteins that are important for membrane trafficking and MVB biogenesis. The discovery of two viral proteins
and their host interactions strongly position us to define the mechanisms by which CMV modulates membrane
trafficking and MVB biogenesis. We hypothesize that UL135- and UL136-host interactions co-opt host
membrane trafficking and MVB pathways to modulate virus replication. Three aims are proposed to address
this hypothesis. We will define the association of UL135 and UL136 with subcellular membrane compartments
and host proteins in Aim 1. In Aim 2, we will define the significance of host interactions to virus replication,
membrane trafficking, and incorporation of cargo into MVBs to understand the mechanistic basis of CMV-
mediated control of host trafficking. Finally, we will investigate the role of UL135 and UL136 and their host
interacting partners in regulating MVB biogenesis and determine how this regulation impacts viral egress. Our
studies will define the virus-host interactions and trafficking pathways targeted by CMV and their significance to
infection. Furthermore, we anticipate that our findings will uncover common strategies used by many viruses to
manipulate trafficking pathways.

Public health relevance
PROJECT NARRATIVE This proposal addresses issues of central importance to the success of virus infection in the human host: how virus co-opts cellular membrane trafficking pathways to achieve the goal of replication in target cells in the host. This work will increase our understanding of virus-host interactions that impact viral spread, persistence and disease in the context of congenital infection, transplantation, immune suppression, and aging.